INTELLECTUAL PROPERTY CONSULTING QUOTE FOR SERVICES FOR CONTRACEPTION RESEARCH

The purpose of this contract is to provide Program with consulting services (e.g., opinions) for the betterment of a given contraceptive research program. The services are responsive to a need identified by the Contraception Research Branch (CRB) to review intellectual property related materials and make informed decisions on identified funded research (e.g., grants and/or contracts).